Unveiling the hidden regulators: deciphering endogenous retroelement control of allergic Type 2 immune response

SUMMARY
The global burden of pulmonary allergic diseases, including asthma, continues to rise, with an estimated
262 million cases worldwide. House dust mites (HDM) are among the most common aeroallergens, sensitizing
85% of asthma patients. The pathogenesis of pulmonary allergic diseases is multifaceted, involving genetic,
epigenetic, environmental, and host factors. While the components and functions of Type 2 immune mediators
driving allergic responses are well understood, the early immunological triggers that initiate Type 2 immunity at
mucosal barrier surfaces remain unclear. Given that 10% of the mammalian genome consists of endogenous
retroviruses (ERVs) and that their reactivation has been linked to the progression of several diseases, though
not yet studied in the context of allergies, this pioneering study will investigate the role of ERVs in the early
development of Type 2-dominated inflammation in the lungs induced by HDM. We hypothesize that the
reactivation of ERVs during allergen sensitization fine-tunes Type 2 immune responses in the mucosal
epithelium, affecting Th2 cells, eosinophils, mucus production, and IgE levels, ultimately exacerbating allergic
phenotypes. Building on preliminary data showing upregulation of ERVs in both human and mouse allergic
tissues, as well as in lung epithelial cell lines stimulated with HDM allergens, this research will explore the
downstream effects of Type 2 allergic inflammation triggered by HDM-induced ERV reactivation (Aim 1) and
investigate the upstream regulatory epigenetic pathways that modulate ERV expression during allergic
inflammation (Aim 2). Using in vitro and in vivo conditional knockout mouse models and employing advanced
techniques such as multiparameter flow cytometry, high-throughput cytokine and chemokine profiling, bulk and
single-cell RNA sequencing, and ATAC-seq in allergic tissues and human and mouse epithelial cell lines
stimulated with HDM, this study will provide insights into when, where, and how ERVs regulate downstream Type
2-associated allergic responses following HDM sensitization. Key components of the research include mapping
ERV reactivation in the allergic airway mucosa, analyzing the temporal dynamics of ERV reactivation during the
development of Type 2 inflammation, assessing the effects of ERV depletion (using mutant mice) or blockade
(with antiretroviral drugs) on Type 2 inflammatory responses in the lungs, and investigating the epigenomic
regulation of ERV-induced Th2 responses. By unraveling the intricate network involving the endogenous virome,
the mucosal barrier, and HDM-driven pulmonary Type 2 immunity, we will take allergy research in a new direction.
We will explore the previously unexamined role of endogenous retroelements in regulating Type 2 immune
responses in both mouse and human models, which may ultimately pave the way for new therapeutic strategies
against asthma and related conditions.

Public health relevance
NARRATIVE Pulmonary allergic diseases, including asthma, represent a growing global health challenge, with over 262 million cases linked to common aeroallergens like house dust mites (HDM). This study aims to uncover the role of endogenous retroviruses (ERVs) in initiating HDM-induced Type 2 immune responses at mucosal barriers, hypothesizing that their reactivation during allergen sensitization enhances allergic inflammation. By utilizing advanced next-generation sequencing analysis of the transcriptome and epigenome, conditional knockout mouse models, and in vitro models of human and mouse cell lines, we will elucidate how ERVs influence Type 2 immunity, ultimately paving the way for new therapeutic strategies against asthma and related conditions.